T Cell Differentiation in Tissue Microenvironments

ABSTRACT
Support is requested for a Keystone Symposia conference entitled T Cell Differentiation in Tissue
Microenvironments, organized by Drs. Greg Delgoffe, Amanda Lund, Nikhil Joshi and Laura Mackay. The
conference will be held in Vancouver, British Columbia, Canada from February 2–6, 2025.
Normal and pathological immune responses function across tissues that harbor unique metabolic,
environmental, and cellular microenvironments. Therefore, the mechanisms that recruit and activate leukocytes,
define their interstitial function and survival, or promote their retention in particular tissues are crucial to
understanding how to boost, redirect, or restrict immune responses across the spectrum of health and disease.
While the topic of tissue specific immunity has been touched on in other meetings, this is the first conference to
integrate discussion across diverse tissues and disease contexts. The program will cover how various tissues
shape the immune responses that are generated within, while highlighting emerging technologies that are
enabling advancements in this field. The speaker lineup will attract a vast array of multidisciplinary scientists
thinking about T cell differentiation in tissues in the context of diverse diseases, such as cancer, autoimmunity,
and infection. In addition, as a joint meeting with the Keystone Symposia conference on Innate Immune Memory:
Mechanisms and Consequences, the intersections of audiences and researchers will enable dynamic crosstalk,
cross-disciplinary insights and collaboration towards understanding the interconnectedness of innate and
adaptive immunity, and interplay with tissue microenvironments.

Public health relevance
PROJECT NARRATIVE T cells are an important class of white blood cells that mediate immune responses by targeting foreign antigens throughout the body. Because T cells act in many tissues, the local microenvironment where they work plays an important role in T cell differentiation and action. This Keystone Symposia conference brings together a multidisciplinary group of researchers who are exploring the many ways in which surrounding tissue can influence T cell-based immune responses, including in therapeutic contexts, such as affecting the success of cancer immunotherapy.